Core--Animal facility

DESCRIPTION (Adapted from the application) The main goal of this core is to support and optimize the activities of the investigators performing studies with animals. This core will provide services in a. breeding and maintaining normal, congeneic, and gene-deficient mice with reproducible enteric microbiota and clinical disease in both conventional and specific pathogen-free housing, and b. generating germ-free and mono-associated infected mice. This core will provide support to Projects 2, 3 and 4.